Disparities in Trust: COVID-19's Impact on Minority Veterans' Healthcare Experiences

Background: Patients who distrust their healthcare providers are less likely to seek care or comply with
medical regimens, potentially exacerbating negative downstream impacts on overall health. Previous research
on Veterans’ experiences of healthcare has found low trust and high perceived discrimination among Latinx
Veterans. Nuances unique to Latinx populations have been understudied in the context of medical distrust.
Given the demographic transformation of the US Armed Forces and increasing population of Latinx Veterans
expected to seek VA care, it is important to better understand Latinx Veterans’ healthcare experiences and
how those experiences may contribute to medical distrust.
Significance/Impact: Research findings will provide evidence to support strategies for improved
implementation of healthcare practices that are more sensitive to race and ethnicity and can reduce medical
distrust and improve engagement with VA care by the already vulnerable, high-risk Latinx Veteran population.
Innovation: While prior studies hint at factors contributing to medical distrust in patients overall, research has
yet to investigate this phenomenon among Latinx patients specifically. We lack data that explores possible
connections between medical distrust and specific health outcomes, and we need studies that
comprehensively examine connections and contradictions between quantitative survey responses and
qualitative interview remarks. This proposal’s conceptualization of medical distrust as central to our research
question and mixed-methods approach makes the proposed study both novel and necessary.
Specific Aims: Through this work we will better understand how medical distrust may influence health
outcomes in Latinx Veterans, the extent to which knowledge and information about VA gained from social
networks influences medical distrust, and Latinx Veterans’ definitions of medical distrust.
Aim 1. Describe the association between medical distrust and health outcomes among Latinx patients.
We will estimate the association between patient indication of medical distrust and self-reported health
outcomes.
Aim 2. Assess social network influence on medical distrust among Latinx Veterans. We will examine the
extent to which positive and negative social network influence is associated with medical distrust by combining
results from semi-structured interviews and quantitative close-ended surveys.
Aim 3. Seek Latinx Veteran input on current measure of medical distrust and cultural sensitivity. We
will also conduct semi-structured cognitive interviews with 25 Latinx Veterans participating in the parent study
to learn patients’ perspectives on how medical distrust is currently measured.
Methodology: Participating Veterans will complete a survey and semi-structured interview asking about their
sources of medical distrust in 12 domains of health care. Findings from these surveys and interviews will be
analyzed using quantitative methods (for close-ended survey responses) and qualitative methods (for open-
ended responses from interviews (Aim 3)). A concurrent mixed-methods approach will also be employed to
generate a more complete assessment of findings (Aims 1 & 2).
Next Steps/Implementation: Study findings will inform a future VA Career Development Award proposal to
develop strategies for implementation of healthcare practices that are more sensitive to race and ethnicity.

Public health relevance
Latinx Veterans are more likely to experience low trust and high perceived discrimination while receiving VA care compared to White Veterans. Medical distrust in providers, healthcare entities, and medical research has been proposed as a possible explanation for such disparities. Medical distrust is high in marginalized populations. Causes of medical distrust are understudied and not previously well validated, specifically among Latinx patients. This study will examine the relationship between medical distrust and health outcomes in a national sample of Latinx Veterans from the perspective that patient health disparities emerge from sequential and overlapping influences at the individual (patient) and interpersonal (social network) levels.